Advancing measurement of physical function in upper limb amputation

Although improving physical function (PF) is a primary goal of prosthetic rehabilitation, measurement of PF
in persons using upper limb prostheses is challenging due to limitations of existing measures and challenges in
implementing standardized data collection in routine care settings. In the past decade, my research team has
tested, developed, and refined patient-reported outcome measures (PROMs) as well as performance-based
measures of PF for upper limb amputation (ULA). We developed three promising condition-specific PF
measures for ULA, the Upper Extremity Functional Scale for Prosthesis Users (UEFS-P), a custom 13-item
version of the Patient-Reported Outcomes Measurement Information System (PROMIS) Upper Extremity
Measure (PROMIS-13 UE Amputation sample-specific calibrated scoring AMP) and the Activities Measure for
Upper Limb Amputation (AM-ULA). We also evaluated several versions of short forms (SF) of the Patient-
Reported Outcomes Measurement Information System upper extremity measure (PROMIS-UE SF). This work
has identified important gaps that should be addressed to ensure that measures are reliable, valid, and
responsive to change in women and men with ULA.
We demonstrated known group validity and test-retest reliability of the UEFS-P (which consists of a
One-handed and a Two-handed Task scale). However, the One-handed Task scale had poor person reliability
and a substantial floor effect. In addition, the Two-handed Task scale was long and burdensome. The
PROMIS-13 UE AMP was scored using amputation-specific calibration and had better reliability than PROMIS-
UE SF measures scored using generic population calibrations. However, it could not detect differences in
scores between prosthesis users and non-users at the same amputation level, limiting its usefulness for
comparisons by prosthesis use and for evaluating effects of prosthetic rehabilitation. To date, the UEFS-P and
PROMIS-13 UE AMP have been administered by telephone, though other modes of administration are
preferable in clinical settings. Data to support equivalence and feasibility of other administration modes is
needed.
The long-term goal of this research is to provide clinicians and researchers with tools to evaluate and
address the needs of women and men with ULA. The rationale for this proposal is that valid, reliable, and
responsive PF measures are needed to detect disparities by sex, accurately track function over time, and
discern effects of prosthesis characteristics and prosthesis training. The overall aim of this proposal is to
advance the measurement of PF in ULA by refining the UEFS-P and the custom PROMIS-UE SF as well to
provide tools to facilitate implementation of the measures. The specific aims of the study are to: 1) refine
content, evaluate measurement properties, and improve utility of the UEFS-P and custom PROMIS-UE SF; 2)
test the equivalence of the refined UEFS-P and PROMIS UE SF measures by mode of administration; and 3)
develop clinical translation tools to facilitate adoption of study measures.
This study will advance state-of-the-art measurement of PF in ULA and provide translational tools to
expedite measure adoption, ultimately driving improvements in care quality and research design. This work
directly addresses a priority identified by the VA/DoD Management of Upper Limb Amputation Rehabilitation
Work Group. Key outcomes include: 1) a refined UEFS-P One-Handed Task scale with improved reliability, 2)
a short form UEFS-P Two-Handed task scale, 3) a refined population-specific PROMIS-UE SF measure, 4)
evidence of concurrent validity of the UEFS-P and PROMIS-13 UE AMP, 5) comparison of mode of
administration, and 6) tools to facilitate PF measure adoption to be tested in a future implementation study.
1

Public health relevance
The overall aim of this proposal is to advance state-of-the-art measurement of patient-reported measurement of physical function in persons with upper limb amputation (ULA). This study will refine two measures developed by our research team: the Upper Extremity Functional Scale for Prosthesis Users (UEFS-P) One and Two-handed Task scales, and the PROMIS-13 UE AMP, a custom 13-item version of the Patient-Reported Outcomes Measurement Information System (PROMIS) Upper Extremity Measure with amputation-specific scoring. We will develop 3 versions of each measure: paper and pencil, online, and interviewer administered. This study will also develop a Toolkit with content tailored to the needs and preferences of end users within the VA Amputation System of Care to help promote widespread implementation and adoption of the measures in VA clinical care. The measures that we develop will be applicable for use in Veteran as well as non-Veteran populations.